Role of viral BCI-2 mediated anti-apoptosis and-autophagy

[unreadable] DESCRIPTION (provided by applicant): Programmed cell death (PCD) is a major component of host innate immunity against viral infection and tumorigenesis. In addition to a well-characterized apoptosis, autophagy is a new, emerging PCD pathway. Autophagy is an evolutionally conserved and highly regulated homeostasis process by which cytoplasmic components are degraded for removal or turnover via a lysosomal pathway. This process also plays an effective role in anti-microbial and anti-tumor responses by degrading intracellular bacteria and viruses and suppressing cancer cell growth, respectively. Thus, apoptotic and autophagic PCDs are important innate safeguard mechanisms to protect the organism against harmful microbes and unwanted cancerous cells. The goal of this study is to better understand how gamma-2 herpesviruses, including Kaposi's sarcoma herpesvirus (KSHV), herpesvirus saimiri (HVS), and mouse herpesvirus 68 (MHV68), evade host PCD- mediated innate immunity, with a specific focus on the viral Bcl-2, designated as vBcl-2. The loss of vBcl-2 gene from viral genome does not affect the ability of MHV68 and HVS to replicate in culture, nor does it change the acute phase of viral replication in mice and monkeys, respectively. However, MHV68 vBcl-2 mutant exhibits a significant decrease in the latency and reactivation in mice, whereas HVS vBcl-2 mutant no longer induces lymphoma in primates. In addition, gamma-2 herpesvirus vBcl-2 functions not only as an inhibitor of apoptosis by targeting cellular Bax and Bak, but also as an antagonist of autophagy by targeting cellular Beclin1-UVRAG tumor suppressor autophagic complex. Based on these findings, we hypothesize a novel viral immune evasion and pathogenic strategy where vBcl-2 targets both apoptosis and autophagy to escape host PCD-mediated innate immunity and tumor suppression, and that its anti-apoptotic and anti-autophagic activity contribute to the persistence and pathogenesis of gamma-2 herpesvirus in distinctive manners. The proposed research is initially focused on characterizing vBcl-2 mutants to differentiate its anti-apoptotic and anti-autophagic function (Aim 1), followed by investigating how vBcl-2 antagonizes apoptosis (Aim 2) and autophagy (Aim 3). To correlate the effect of vBcl-2 on apoptosis and autophagy with viral persistence and pathogenesis, we will test how the loss of vBcl-2 activity to subvert apoptosis and/or autophagy affects MHV68 persistence and HVS pathogenesis in mice and primates, respectively (Aim 4). With well-established in vitro and in vivo experimental conditions, the proposed study will detail the role of vBcl-2 as an apoptosis and autophagy antagonist in gamma-2 herpesvirus persistence and pathogenesis. [unreadable] [unreadable] [unreadable]